NICHD Neonatal Research Network - Stanford University

PROJECT SUMMARY
The Division of Neonatal and Developmental Medicine at Stanford University submits a competing renewal
application to participate in the NICHD Neonatal Research Network (NRN). The Division and its faculty
members have a long history of innovative research accomplishments in neonatal medicine. This expertise
dovetails with the NRN goal of conducting definitive and rigorous multicenter trials and observational studies in
newborns to improve survival without neurodevelopmental impairment. As a participant in the NRN since 1991,
this center has proven to be highly productive, contributing to leadership, study design, protocol development,
execution, analysis, and results dissemination. Led by PI, Krisa Van Meurs, Alternate PI, Valerie Chock, and
Follow-up PI, Susan Hintz, the site neonatologists and subspecialty collaborators have wide-ranging expertise
and significant clinical research experience with 613 manuscripts published in neonates since 2016. Within the
NRN, Stanford investigators have 55 subcommittee assignments and appear as co-authors 117 times on NRN
manuscripts. Dr. Van Meurs is Chair of the Publications Committee and coordinated 131 manuscript reviews,
spearheaded a review of NRN policies leading to a reduction in time to publication, and was Editor for the
Seminars in Perinatology volume describing NRN contributions over the last grant cycle. As Lead Follow-up PI
and Chair of Follow-up Protocol Development, Dr. Hintz has been responsible for advancing protocols and
proposals, and assuring the quality of NRN follow up visits, and enhancing rigor of training and certification
procedures. During the COVID pandemic she led re-envisioning of certification processes, launched new tools,
and developed individualized improvement plans for challenged sites. Cody Arnold is Co-PI for the ongoing
Cycled Phototherapy trial. Valerie Chock led a NHLBI-funded secondary to the Transfusion in Prematures trial
on near-infrared spectroscopy (NIRS), Dr. Van Meurs led a secondary to the Optimizing Cooling trial on
amplitude-integrated EEG, and Courtney Wusthoff led a secondary study to the Preemie Hypothermia trial on
EEG. Stanford neuroradiologists have been MRI central readers for all the NRN cooling trials. The Stanford
site with its 2 satellite sites, El Camino Hospital and Santa Clara Valley Medical Center, provide an annual
delivery base of >12,000 births with 59% born to high risk mothers, 140 NICU beds, and >1900 NICU
admissions with 83% inborn. Two sites anticipate growth in deliveries over the next 3 years. Our aggregate
population is diverse in comparison to the rest of the US with 25% Asian and 52% Hispanic. Over the last 6
grant cycles Stanford has demonstrated wide-ranging expertise, exceptional leadership, and strong
collaborative abilities that have served the NRN well. One of the greatest strengths Stanford has to offer is our
extensive and talented pool of young clinical investigators that will become the clinical research leaders of the
future. In summary, the Stanford site has the neonatal and subspecialty faculty, physical space, research
resources, professional staff, institutional support, and patient population necessary to continue as one of the
finest centers participating in the NRN.

Public health relevance
PROJECT NARRATIVE The objective of the NICHD Neonatal Research Network is to improve healthcare and neurodevelopmental outcomes for newborns born premature, low birthweight, or with other serious conditions by performing rigorous and reproducible multi-site clinical trials and observational studies. This consortium of academic medical centers provides the neonatal population and faculty expertise to advance the field of neonatal- perinatal medicine. New opportunities are provided with new protocol proposal and selection processes as well as encouraging the participation of investigators from outside the Network.